Biomarkers for Peripheral Circadian Clocks in Humans

PROJECT SUMMARY/ABSTRACT
Circadian clocks are present in most tissues of the body with importance for optimal physiological function and
behavior. Misalignment or disruption of peripheral circadian clocks contribute to disease and thus represent
promising novel treatment targets to improve health. The overall goal of this proposal is to improve our
understanding of peripheral circadian clocks in humans. We will conduct a seven-weeklong randomized,
crossover, mechanistic clinical trial to 1) test zeitgebers (time cues) for already identified markers of peripheral
clocks, and 2) identify novel biomarkers for peripheral clocks and explore zeitgebers for those clocks in humans.
Preliminary data from our human circadian basic and clinical trial research set the stage for this proposal. This
mechanistic clinical trial effort is a first step to inform future development of novel circadian based treatments for
aligning peripheral clocks and for developing novel circadian biomarkers that will advance our scientific
understanding of circadian rhythms. Our overall goal and aims support the NIH Precision Medicine Initiative and
the NIH Sleep Disorders Research Strategic Plan.

Public health relevance
PROJECT NARRATIVE Circadian clocks are present in most tissues of the body with importance for optimal physiological function and behavior. This project will utilize rigorous circadian approaches to systematically test novel hypotheses about the regulation of known biomarkers of peripheral circadian clocks in humans, and for discovery of new biomarkers of peripheral clocks in humans. We anticipate our findings will be the first step in developing novel circadian based treatments for aligning peripheral clocks and for developing novel circadian biomarkers that will advance our scientific understanding of circadian rhythms.